Prevention Research Centers' Cancer Prevention and Control Research Network: UPenn Prevention Research Center

PROJECT SUMMARY
The University of Pennsylvania Prevention Research Center (UPenn PRC) is submitting this application to
become a Collaborating Center of the Prevention Research Centers’ Cancer Prevention and Control Research
Network (CPCRN). This center will work with partners to accelerate the implementation of evidence-based
cancer prevention and control strategies. The UPenn PRC’s CPCRN Collaborating Center will be an active
participant in the Cancer Prevention and Control Research Network, engaging in research and practice
activities that span the translation continuum from discovery to the dissemination and adoption, maintenance
and sustainability of effective interventions. Promoting health equity in underserved and minority communities
through improved access to evidence-based cancer prevention and control strategies is a major focus of the
CPCRN center’s activities.
The UPenn PRC Collaborating Center of the CPCRN will lead and manage a program of community-based
cancer prevention and control research. The Center will strengthen partnerships to advance community-based
intervention research in cancer prevention and control; translate and disseminate study tools, methods, and
findings; and expand community-engaged dissemination and implementation research related to cancer
prevention and control. Our center’s main activities will include CPCRN Network participation, collaboration on
CPCRN Network workgroup projects, a core research project, and a training initiative. The core research
project will implement and evaluate evidence-based strategies to increase cancer risk assessment and risk-
stratified management for breast and colorectal cancer, for disadvantaged and minority adult patients at
Federally Qualified Health Centers. The CPCRN Scholars Program will help to prepare the next generation of
cancer prevention and control implementation science and health equity researchers.
The diverse leadership of the proposed CPCRN center team has extensive experience in intervention and
dissemination and implementation research, cancer prevention and control, and community-based
participatory research. This center will support the work of a multidisciplinary team of co-investigators with
expertise in cancer epidemiology, health services research, cancer screening, genetic counseling and testing,
health disparities research and action, and health communication. Together with the network and our partners,
this CPCRN center will advance research across the translation continuum to promote the adoption of effective
cancer prevention and control interventions.

Public health relevance
PROJECT NARRATIVE The CPCRN Collaborating Center at the University of Pennsylvania will work with the CPCRN network and partners to accelerate the implementation of evidence-based cancer prevention and control strategies in communities and enhance large-scale efforts to reach underserved populations, reduce cancer risk, improve screening utilization, reduce death from cancer, and ameliorate health disparities in the community and within health systems. The main activities of the UPenn PRC collaborating center will be CPCRN Network participation, participation in CPCRN workgroup projects, and two Center-specific initiatives: 1) our core research project, Implementation Research to Increase Risk Assessment and Referral for Breast and Colorectal Cancer in Federally Qualified Health Centers, and 2) the CPCRN Scholars Program.